CELLULAR AND MOLECULAR BASIS OF GAMMA/DELTA T CELL ANTIGEN RECOGNITION

PROJECT SUMMARY/ABSTRACT Gamma/delta (γδ) T cells are specialized immune cells that are thought to be a first line of defense against major infections. They are known to be activated early during infections such as tuberculosis, malaria, and bacterial meningitis. γδ T cells recognize and respond to infectious agents using a receptor (the γδ antigen receptor, or γδ TCR) on their surface, which binds to parts of infecting organisms (antigens) or other molecules on infected cells that indicate their presence. In addition to recognition of invading organisms by the γδ TCR, other `costimulatory' and `accessory' surface receptors cooperate to generate biochemical signals to activate the cell. This results in the release of proteins that kill infected cells (eg. perforin), as well as soluble factors (eg. cytokines IFNγ and IL-17) that attract other types of immune cells, such as neutrophils and conventional αβ T cells, to sites of infection and inflammation. Surprisingly little is known about how the γδ TCR, along with associated accessory and costimulatory receptors, work to activate the cell. These molecular interactions, which together form the basis for antigen recognition, is thought to take place at a specialized junction that forms between γδ T cells and infected cells known as the immunological synapse, but how it is organized and functions is unclear. It also seems that γδ T cells must recognize components of infecting organisms when they are bound to other `presenting' molecules on the cell surface. However, the identity of these molecules and the strategies used by γδ TCRs to recognize them, remain obscure. These uncertainties about how γδ T cells recognize and are activated by infections present major impediments to their effective harnessing in treatments and vaccination strategies targeting these diseases. I aim to understand the molecular underpinnings of γδ T cell function using advanced in vitro and in vivo imaging technologies, to identify mechanisms of immune activation in these cells that are critical for their role in responding to infections. This work will lead to a more detailed understanding of these medically relevant immune cells, and may contribute to the design of strategies to enhance our immune defenses by boosting γδ T cell function.

Public health relevance
PROJECT NARRATIVE Gamma/delta () T lymphocytes are specialized immune cells that are a first line of defense against major infections and malignancies. Surprisingly little is known about how they function, which hampers their effective exploitation in therapies targeting these diseases. I aim to understand the molecular underpinnings of  T cell function with the ultimate goal of using this knowledge to enhance our immune defenses by boosting their function.